Mechanism of kindlin-3-dependent integrin activation

Description
This is project 2 of the PPG “Cellular Mechanisms of Inflammation, Hemostasis, and Thrombosis”. Kindlin-3 is
known to be required for integrin activation in platelets and leukocytes. This is starkly illustrated by the human
disease Leukocyte Adhesion Deficiency-III. Patients with this disease have mutations in FERMT3, the gene
encoding kindlin-3, and suffer from life-threatening bleeding and bacterial infections. Infections result because
kindlin-3-deficient leukocytes including neutrophils cannot adhere to the vessel wall and thus fail to recruit to
sites of infection. Neutrophils express two β2 integrins, αLβ2 and αMβ2. We made and validated a humanized
mouse in which human β2 was knocked into the mouse β2 locus. In this mouse, β2 integrin activation can be
monitored by binding of mAbs 24 and KIM127, specific for activation epitopes in human β2. We propose to use
flow cytometry, live cell imaging by quantitative dynamic footprinting, superresolution microscopy by
SuperSTORM, recently developed in the Ley lab, and intravital microscopy in the β2 integrin humanized
mouse to address three specific aims: Specific Aim 1 is to test the role of the kindlin-3 PH domain in β2
integrin activation. We hypothesize that the PH domain is required for kindlin-3 recruitment to the plasma
membrane. We use retrovirally transduced neutrophilic cells expressing fluorescent fusion proteins of kindlin-3.
For in vivo assessment, we transduce kindlin-3-deficient hematopoitic stem cells with vectors encoding kindlin-
3 fusion proteins to achieve expression in primary mouse neutrophils in vivo. Specific Aim 2 is to test the
importance of kindlin-3 dimerization. Dimerization will be assessed by Förster Resonance Energy Transfer
(FRET), both in total internal reflection (TIRF) microscopy (near the membrane) and by confocal microscopy (in
the cytosol). We hypothesize that the PH domain also may contribute to dimerization, similar to the
dimerization of sharpin, which is studied in project 4. Specific Aim 3 is to test how kindlin-3 interacts with
talin-1 and β2 integrins. To test this, we make use of the existing mCherry FP-talin-1 transgenic mouse, since
talin-1 is too large for retroviral packaging. F(ab) made from the β2 integrin activation reporters KIM127 and
mAb24 will be used to assess β2 integrin conformations in vitro and, using the human β2 integrin knockin
mouse, in primary neutrophils in vivo. Project 2 will closely collaborate with project 1 by conducting live cell
and superresolution imaging to address the role of Rap-1 binding for talin-1 function. Project 1 investigators
will assist project 2 with various biochemical assays. When the proposed work is completed, we will
understand how kindlin-3 and talin-1 cooperate to enable β2 integrin-dependent neutrophil arrest under flow.